Administrative Core

ABSTRACT: Administrative Core
The National Dementia Workforce Study (NDWS) will be launched by a national team of experts in clinical care
of persons living with dementia, survey research, and health workforce research. The goal of the NDWS data
infrastructure is to allow researchers and policymakers to ask and answer scientific questions to help build the
workforce of clinicians and other professional care providers required by the growing population of persons
living with dementia in the U.S. The core of NDWS will be four surveys that reflect key elements of the
professional dementia care workforce in the U.S.: Community Clinicians, Nursing Home Staff, Assisted Living
Staff, and Home Care Staff. In addition to these surveys, the NDWS team will develop a variety of additional
data sources that can be linked with the surveys in order to maximize the scientific potential of the surveys.
The Administrative Core will be responsible for the overall organization, management, decision-making, and
communication for NDWS, including coordinating knowledge dissemination activities to ensure that the
research community is aware of the tremendous new data infrastructure that will be created by this project.
The Administrative Core will provide oversight and consultation to each of the Cores to ensure that scientific
objectives are met and that there is optimal utilization of resources. Specifically, the Administrative Core will: 1)
Administer, manage, and integrate all elements of the NDWS cooperative team; 2) Coordinate and integrate all
elements of the NDWS data products; 3) Develop and disseminate data products, guidance materials, and
training opportunities to ensure full and timely use of the four NDWS surveys and available linked data; and 4)
Coordinate stakeholder engagement—including persons living with dementia, their caregivers, dementia
workforce providers, and institutional leaders—across the Cores to maximize the utility and potential impact of
NDWS.